Translation of GluN2B-selective PET radiopharmaceuticals in Alzheimers patients

Project Summary. At present, there are no efficacious therapies for Alzheimer’s disease (AD) to halt or slow disease
progression, which is attributed, at least in part, to the lack of translational cross-species molecular imaging tools
suitable for use in both preclinical disease models and in humans to facilitate drug discovery and development.
Therefore, the development of translatable imaging biomarkers for non-invasive assessment of disease progression
and therapeutic efficacy hold promises to fill this urgent and unmet medical need. N-Methyl-D-aspartate receptor
(NMDAR) plays a pivotal role in the synaptic transmission and synaptic plasticity thought to underlie learning and
memory. NMDAR activation has been implicated in AD related to synaptic dysfunction, which leads to gradual loss of
synaptic function and correlates clinically with the progressive decline in cognition/memory of AD patients. Therefore,
in vivo imaging of GluN2B is of paramount translational relevance as it would allow the assessment of GluN2B
distribution and expression of AD patients, enabling correlational study between NMDAR-mediated excitotoxicity and
neuroimmune factors during AD progression and providing target engagement tool to support novel AD
pharmacotherapy.
Herein, we propose the use of a novel imaging strategy for monitoring detrimental extrasynaptic NMDAR function
in AD. Our strategy entails the use of a novel positron emission tomography (PET) tracer, [11C]Me-NB1, that targets
GluN2B-carrying NMDAR. To date, [11C]Me-NB1 is the only GluN2B PET tracer that has been successfully validated
in naïve animals and recently tested in a small number of healthy subjects. Our preliminary studies have shown that
[11C]Me-NB1-PET is highly suited for non-invasive mapping of the GluN2B subunit, with excellent target affinity and
selectivity across different species. However, non-invasive assessment of the distribution and expression of GluN2B
has not yet been conducted in AD patients and clear evidence is still deficient in demonstrating the underlying
mechanisms and a relationship between NMDAR dysfunction and AD. The availability of [11C]Me-NB1 now provides
new opportunity to fill this fundamental knowledge gap. Therefore, we have developed three objectives and hypothesis
in this work: (1) A kinetic modeling approach and absolute quantification, and/or simplified graphical methods of
[11C]Me-NB1 can be established in healthy controls; (2) PET quantification method will be translated into AD patients
and we expect increased GluN2B binding in vitro and in vivo by [11C]Me-NB1-PET is positively correlated with AD-
related brain regions in AD patients (versus controls); (3) As proof-of-concept, in transgenic AD mouse models, we
anticipate that [11C]Me-NB1-PET can directly monitor GluN2B changes and enable target occupancy studies during
novel AD therapy. Overall impact: The role of glutamate-induced neurotoxicity in AD renders NMDAR subtype GluN2B
a potential drug and imaging target. [11C]Me-NB1-PET can not only track GluN2B changes and measure target
occupancy during novel AD therapeutic interventions, but also will support smaller, shorter trials for proof of
mechanism and also to facilitate optimal patient selection for clinical trials.

Public health relevance
Project Narrative As the burden of Alzheimer’s disease and related dementias in the United States and worldwide is high, there is a critical and unmet clinical need to develop and translate novel positron emission tomography (PET) imaging tools to study neurodegeneration-related biological processes in the brain. This work will validate and translate key imaging ligands in humans designed to substantially advance our scientific understanding of subtype-specific N-methyl-D-aspartate receptor and its role in the pathophysiology and glutamatergic signaling transduction pathway of Alzheimer’s disease (AD), facilitating drug discovery of novel neurotherapeutics for AD patients.